In situ mechanisms of biological nitrogen fixation

PROJECT SUMMARY. Nitrogen fixation by the metalloenzyme nitrogenase supports nearly 50% of the global
population and is the only biological pathway for nitrogen reduction. Nitrogenase consists of two proteins, the
obligate reductase Fe-protein and the catalytic MoFe-protein, both of which are rapidly inactivated by oxygen.
Biochemical, crystallographic, and spectroscopic studies have yielded seminal insights into the structures and
functions of purified nitrogenase proteins, but a unified understanding of the enzymatic mechanism is still
unrealized. These proteins are expressed in a small subset of prokaryotes termed diazotrophs, including aerobes
and anaerobes, which inhabit a diverse array of environments. Despite this evolutionary demonstration of
compatibility between nitrogen fixation and a variety of metabolisms, robust heterologous expression of the
nitrogenase proteins has not been achieved. Instead, endogenous expression within the free-living soil bacterium
Azotobacter vinelandii remains the most widely used system for the purification and study of nitrogenase. Several
peculiar features of this obligate aerobe have been annotated under nitrogen-limited conditions, to wit, the
formation of an intracytoplasmic membrane network, but a comprehensive investigation of these features and
their relationship to the nitrogenase proteins is lacking. The primary hypothesis of this proposal is that
interactions with cellular ultrastructures and as yet unidentified binding partners in vivo significantly
regulate and promote nitrogenase activity. My goal is to identify and characterize these states of nitrogenase
in diazotrophic organisms by training in and applying emerging cryoelectron tomography (cryoET) methodologies
and performing experiments outlined in two Aims. Aim 1: Revealing the architecture of the nitrogenase
interactome in A. vinelandii with mass spectrometry and single particle (SP) cryoEM. Aim 2: Determining in situ
structures of nitrogenase complexes in conjunction with cellular features using cryogenic correlative light and
electron microscopy (cryoCLEM/ET) and sub-tomogram averaging (STA). As a postdoctoral fellow I have gained
expertise in anaerobic SP cryoEM to obtain high resolution structures of nitrogenase. These skills will provide a
foundation for the proposed research. However, I seek training in the growing field of cryoET for the study of in
situ structures. Throughout the outlined aims, I will train in genetic manipulation of non-model organisms, mass
spectrometry, and cryoET from my advisory committee, the Caltech CryoEM and proteomic facilities, and
national facilities while continuing to expand my mastery of SP cryoEM and metalloenzyme chemistry. In my
independent career, I will apply this training to the continued study of nitrogenase and other anaerobic systems
relevant to environmental and human health. The proposed aims will yield the first comprehensive investigation
of nitrogenase in situ with the increasingly high resolution technique of cryoET, and will provide insight not only
into cellular regulation of nitrogen fixation, but also structures of true turnover states within the cell thus
fundamentally moving our understanding of this important biogeochemical process forward.

Public health relevance
PROJECT NARRATIVE. Biological nitrogen fixation by nitrogenase sustains life on Earth through the production of metabolically available nitrogen for incorporation into essential biomolecules. The proposed research targets select aerobic and anaerobic diazotrophic bacteria with emerging cryoET methodologies to answer key questions about the nitrogenase enzymatic mechanism in the cellular context. Examining the structure function relationships of nitrogenase in this context will inform on other metalloenzyme mechanisms enzymes relevant to human health, and on the design of synthetic systems for the sustainable production of ammonia for agriculture.